Uncovering the Biochemical Mechanisms of Riboregulatory Interaction Involving the Hepatitis C Virus 3'X RNA

PROJECT SUMMARY
The hepatitis C virus (HCV) is a nanoscopic lipid-enveloped biological entity. Despite the existence of highly
effective treatment plans, this pathogenic particle remains responsible for thousands of deaths each year in the
United States. At the core of this particle lies a genetic message comprised of a single RNA molecule, the vast
majority of which encodes for a roughly 3000 amino acid-long polyprotein. However, there are 98 nucleotides at
the very end of the single-stranded HCV genome that do not encode proteins and yet are essential for the virus.
These nucleotides make up the so-called 3ʹX RNA, which is a structured and highly conserved RNA element
that has been implicated in the regulation of several different RNA-dependent viral processes like replication,
translation, and particle assembly. Many research groups have proposed that this riboregulatory behavior arises
from this RNA's ability to form mutually exclusive interactions with other highly conserved RNA elements within
the HCV genome. Unfortunately, the fundamental biochemical principles governing these RNA-RNA interactions
have not yet been established, which greatly limits our ability to predict which of these mutually exclusive
interactions will be formed under specific conditions and ultimately how the formation and disruption of them
regulate various viral processes. This research project will begin to address these unknowns by determining the
major structural, energetic, and kinetic principles that govern these riboregulatory interactions involving the 3ʹX
RNA. These fundamental insights will be obtained by studying fluorescently labeled HCV RNAs at the single-
molecule level using FRET spectroscopy and microscopy with additional support from cryo-electron microscopy
as well as more conventional electrophoretic and chromatographic approaches. Our findings will allow us to
construct a quantitative physical model that highlights the biochemical function of this highly conserved non-
coding viral RNA and its various interaction partners. Not only will this knowledge enhance our understanding of
HCV and the diseases it causes, but because these regulatory RNA-RNA interactions often appear in other non-
viral RNAs, it will also positively impact several other areas of general RNA biology.

Public health relevance
PROJECT NARRATIVE Many basic biological processes depend on RNAs that must first adopt specific conformations. Our research will determine how the conformation of a critical RNA element located at the end of the hepatitis C virus genome changes when it interacts with other viral RNAs and how these conformational transitions control essential biological processes like viral replication and assembly. The insights made during this project will elucidate the fundamental biochemical mechanisms governing the function of this specific viral RNA element and contribute to a more comprehensive understanding of the functional capabilities of non-protein coding RNAs.